Dual frequency intravascular ultrasound for super-resolution imaging of vasa vasorum and thin fibrous cap of vulnerable atherosclerotic plaques

PROJECT SUMMARY
The underlying mechanism for up to 75% of acute coronary syndromes (ACS) of myocardial infarction is
considered to be due to vulnerable atherosclerotic plaques (AP) rupture. The increased density of coronary
vasa vasorum (VV) around AP has known to be associated with plaque instability and plaque rupture,
especially when the fibrous cap is thin. This strongly suggests that imaging both VV and thin fibrous cap can
be a new strategy for accurate classification, timely intervention, and effective management of the rupture-
prone AP to prevent ACS. Although Intravascular optical coherence tomography (IV-OCT) has shown
promise for vulnerable AP evaluation at high resolution, it has limited imaging depth. Conventional
Intravascular ultrasound (IVUS) has the advantage of improved imaging depth, however, despite successful
clinical investigations in the past decades, a critical technical limitation with spatial resolution remains
unsolved. To overcome the technical challenge and address the unmet clinical need, the goal of this project
is to develop and validate a new super-resolution intravascular ultrasound (SR-IVUS) technology enabling
effective imaging of VV to assess plaque vulnerability with unprecedented high resolution and deep
penetration depth. Specifically, we will develop an innovative, first-of-its-kind 1.75D array at 20 MHz, which
will provide a high-resolution 3D mapping of the VV network at depth. The major benefit of the 1.75D array
is its ability to reject out-of-plane clutter artifacts which are currently challenging in SR realization with a 1D
array. We will also combine a 60 MHz single element broadband transducer for accurately identifying the
thin fibrous cap with the 1.75D array to make a dual mode probe. This enables comprehensive imaging
capabilities for combined, co-registered 3D VV network imaging with morphology and location of the fibrous
cap. Our specific aims are: SA 1: Develop a dual mode SR-IVUS catheter and system. SA 1a: Develop 60
MHz single element transducer and 20 MHz 1.75D array transducer. SA 1b: Integrate 60 MHz single
element transducer and 20 MHz 1.75D array transducer with a configurable high-frequency imaging system.
SA 2: Implement the algorithm of SR-IVUS imaging for vasa vasorum and the fibrous cap thickness
measurement. SA 3: Evaluate the developed prototype SR-IVUS system for imaging the VV and fibrous cap
using rabbit AP model. If successfully developed and validated, the new SR-IVUS device equipped with
high resolution comparable to IV-OCT and at large imaging depth will push forward clinical validation of
IVUS and widespread adoption in clinics with high impact. In particular, during the percutaneous coronary
intervention, the vulnerability of the target culprit plaques and nearby unspecified plaques but have high
potential of future rupture can be more accurately characterized for timely, effective intervention, providing a
paradigm shift in the contemporary management of the vulnerable plaques, a major reduction in morbidity
and mortality associated with AP rupture, and a lasting clinical impact.

Public health relevance
PROJECT NARRATIVE The objective of this project is to develop and validate an innovative diagnostic intravascular ultrasound imaging technology that will allow for minimally invasively detecting coronary atherosclerotic plaques that have high chance of rupturing, which will result in heart attacks. The innovative technology so called super resolution ultrasound imaging provides unprecedented high resolution that enables to image abnormal growth of microvessels in atherosclerotic plaques at great details, which is well known as a key indicator of plaque rupture. Also, thin fibrous cap of the atherosclerotic plaque is prone to rupture. The innovative technology of combining high frequency single element sensor and mid frequency array of sensor, integrated with novel super resolution imaging technique will allow to identify the thin cap and microcvessels respectively in and around the plaques. If successfully validated through novel rabbit atherosclerotic plaque model that is known to be most close to human plaques, the technology development and findings through this project will provide strong foundation and potential for clinical translation. An immediate clinical application will be for percutaneous coronary intervention clinics where this new device will be able to identify plaques at high risk of rupture for most appropriate interventions, treatments to prevent heart attack.